Efficient red-to-NIR photo-uncaging and applications in therapy

PROJECT SUMMARY
Many light-responsive systems have been produced via natural evolution, including opsins, and phytochromes,
while chemists have added to the list of light-responsive molecules for new tools. Scientists have embraced the
use of these light-responsive tools to construct new materials, and we’ve just scratched the surface of the
potential in this important field, particularly in the direction of making efficient red-to-near-infrared (red-to-NIR)
light-responsive groups. The promise of red-to-NIR light resides in deeper penetration depth, less scattering and
absorption by the sample, and less photodamage. Though approaches that use two-photon and lanthanide
nanoparticles exhibit promising progress in allowing red-to-NIR absorption, developing organic-based materials
that work under low power LED light is still challenging and such materials would expand the toolboxes and
facilitate addressing a number of urgent questions. The organic-based platforms will benefit the fundamental
understanding of chemical structure-to-property relationships, as well as impact many intriguing emerging
applications, such as precision drug delivery, neuron modulation, light-triggered reactions, and gene therapy
activation. Because of the much lower photon energy in the red-to-NIR region compared with UV and blue light,
efficient red-to-NIR responsive is still challenging. This proposal aims to develop novel boron-dipyrromethene
(BODIPY) based photo-uncaging groups that build upon weak covalent N-O bond. In particular, the weak
dissociation energy of N-O permits the cleavage after absorbing low energy red-to-NIR photon, which is ideal for
biological and biomedical applications. By varying and modifying the chemical structures, we intend to increase
photo-uncaging efficiency by rigidifying the structure and for the first time facilitate dual cargo release from
BODIPY. After conjugating with a cancer targeting unit, biomedical applications of these novel photo-uncaging
materials will be demonstrated in vitro and in vivo in light-triggered drug delivery. Overall, the capability of efficient
photo-uncaging in the red-to-NIR window will support more advanced experimental designs, and the
convergence of basic research with applications will contribute to expanding knowledge while benefiting
undergraduate researchers for broad impact.

Public health relevance
PROJECT NARRATIVE The high spatial and temporal resolution of light makes optical regulation using the light-responsive group an appealing approach for cellular events controlling, which has broad applications in cell biology, neurobiology, and biomedicine. Due to the fundamentally importance of light-responsive groups and the shortage of tools with effective red-to-near infrared sensitivity, we will try to develop an efficient system using rigidified structures based on weak covalent bond, and apply them in drug delivery for cancer treatment. Given the wide usage of these optical tools in basic science and biomedical application, these techniques would allow timed delivery of targeted bioactive molecules in deep tissue.